Signaling Mechanisms of Lens Development

PROJECT SUMMARY
Defective lens development is a major cause of congenital eye diseases, because the human lens is the
culmination of elaborate cell proliferation, differentiation and morphogenesis, requiring precise regulation by
signaling pathways. A molecular understanding of lens development could potentially lead to new ways of
diagnosing and treating congenital eye diseases originating from defective lens genesis. We have previously
demonstrated that Abl tyrosine kinase modulates actin cytoskeleton remodeling to prevent persistent lens
stalk, a hallmark of Peters anomaly. In this application, we will investigate the direct targets of Abl kinases.
Using conditional mutant mice and cell culture models, we will identify protein tyrosine phosphatase Ptpn12 as
a novel substrate of Abl signaling. Furthermore, we will test the hypothesis that Cas and Paxillin cooperate to
induce Crk signaling in lens morphogenesis. Lastly, we will investigate the role of regulation of Abl interactor
Abi in the lens. As a major signaling pathway, perturbation in Abl signaling can cause not only congenital
disorders but also inflammation, neural degeneration and cancer. Therefore, the study of Abl signaling has far-
reaching implications for both human health and vision research.

Public health relevance
PROJECT NARRATIVE The genetic bases of many ocular syndromes remain unresolved, due to our limit in understanding the mechanism of lens development. This study has the potential to identify the molecular mechanism of Abl signaling in orchestrating lens morphogenesis. Such an understanding will help to guide our efforts in treating ocular-related birth defects.